VAST Center: Viromes Across Space(s) and Time

ABSTRACT
Compared to the human microbiome work focused on bacteria, characterization of the human virome is still
nascent. This is primarily a result of the inherent challenges posed by the viruses, since viruses in human bodies
are highly diverse, small, and generally rare in the context of the microbiome. To address these gaps in
knowledge, our Viromes Across Spaces and Time (VAST) Center will contain a dedicated Biospecimens
Analysis Core (BAC), which will be responsible for extracting, processing, and sequencing the comprehensive
virome and microbiome profiles for all cohorts in our Virome Characterization Center (VCC). The next-generation
sequencing (NGS), molecular, and functional data can then be used by our VAST group, the other VCCs, and
the broader scientific community, to improve our understanding of the human virome.
We will accomplish the goals of the BAC across 3 main aims and several sub-aims. First, we will (Aim 1) optimize
virome enrichment, quantification, and spatial mapping methods, including a pan-virome panel of almost all
currently known viruses, multiple-displacement amplification (MDA) for low biomass samples, and viral-like
particles (VLP) enrichment. Secondly, we will (Aim 2) generate metagenomic and metatranscriptomic sequences
from >15,000 samples and examine sub-cellular, spatial localization of viruses in skin samples, which is essential
for improved understanding of viral localization in tissues. Finally, we will (Aim 3) sequence and annotate long
read viromes from 1,000 high-complexity, longitudinal samples.
Equipped with state-of-art sequencing and imaging technology, our BAC has an unprecedented opportunity to
detect both DNA and RNA viruses in the human body, determine their stability (and dynamics) longitudinally,
map their location in cells, and discover novel viruses from the viral ‘dark matter’. Our aims will (1) capture viral
diversity from different anatomical regions, which likely harbor unique viromes and varied host-environment
interactions, (2) identify novel viruses, thereby enriching our understanding of viral evolution and novel alleles,
and (3) track low-abundance species, which are sometimes pervasive across the body. These data can also
improve measures of viral evolution by curating short-read and long-read data from these cohorts and tracking
their changes over time, which will map host-microbial interactions and tropism at cellular and even sub-cellular
(50nm) resolution. Analyzing these high volumes of diverse data from global and longitudinal cohorts will enable
comprehensive mapping of viral dynamics and biology. Moreover, the generation of high-quality, comprehensive
data on the virome of various tissues and samples will contribute significantly to our understanding of the human
virome, host interactions, and implications in health and disease.